Chemical Probes to Study Methionine Redox Biology

Project Summary/Abstract
Protein methionine residues are emerging as essential redox sites for physiological processes spanning signal
transduction, antioxidant defense, and regulation of protein function. At the same time, aberrant elevations in
methionine oxidation induced by oxidative stress and/or inactivation of methionine sulfoxide reductase
enzymes can contribute to cancer, neurodegenerative and vascular diseases, and life span. To decipher
contributions of methionine redox physiology and pathology, we are developing new chemical reagents to
selectively label reactive methionine sites from proteins to proteomes. The scientific premise is that providing
access to a modular chemical toolbox for methionine bioconjugation will help unveil new functional methionine
sites in proteins to further understanding of physiological and pathological contributions through covalent
methionine tagging. Selective methionine bioconjugation using redox-based probes that emulate the innate
oxidative chemistry of these residues offers chemical innovation, while demonstrating scientific rigor through
the combined use of diverse synthetic, modeling, proteomic, and biochemical approaches to provide general
tools for probing the reactive methionine landscape. Specifically, we seek to (1) design robust and highly
specific oxaziridine probes by establishing a predictive model for tuning selectivity and stability of methionine
adducts, (2) identify proteome-wide oxidatively-sensitive methionine sites and analyze motifs to reveal
principles of methionine hyperreactivity, and (3) biochemically characterize targets involved in reversible redox
regulation, with a particular focus on cancer-dependent targets where methionine oxidation can influence
cellular metabolism.

Public health relevance
Project Narrative (Public Health Relevance Statement) Reversible oxidation and reduction of protein methionines is an emerging mechanism for maintaining cellular homeostasis, contributing to regulation of protein function, cell signaling, and antioxidant defense. Indeed, increased oxidative stress and/or decreased capacity for reduction of methionine sulfoxide to methionine is linked to life-span regulation, neurodegeneration, vascular diseases and thrombosis, and cancer cell proliferation. We are developing new chemical tools to probe methionine with high specificity in protein and proteome settings to identify, biochemically characterize, and provide new imaging reagents for redox- responsive methionine sites important to physiology and disease, particularly in metabolic and oncogenic proteins.